Clinical Utility of Salivary ExRNA Biomarkers for Gastric Cancer Detection

DESCRIPTION (provided by applicant): Extracellular RNA (exRNA) is an emerging paradigm as endocrine signals in cellular communication, biomarker development, therapeutic applications and systemic physiology. This UH2/UH3 project is to test the hypothesis that salivary extracellular RNA (exRNA) can be developed for the clinical detection of human diseases. Our laboratory first reported the existence of a transcriptome and microRNA profile in cell free saliva followed by its scientific characterizations and clinical utilities including biomarker development for molecular oncology applications. Most recently we have performed RNA-sequencing in cell free saliva and reported three major types of RNA in saliva (mRNA, miRNA and snoRNA). This UH2/UH3 application is to test the hypothesis that salivary exRNA can be developed to detect gastric cancer by performing a biomarker development study to definitively validate salivary exRNA biomarkers for the detection of gastric cancer. We are selecting gastric cancer to be the human disease indication because of an ongoing productive collaboration with the Samsung Medical Center where we have already procured saliva from 500 gastric cancer patients and 2250 non-gastric cancer controls. This will permit the UH2 phase for exRNA biomarker discovery to begin immediately. Additional clinical samples will be procured in the UH3 phase, 375 cases and 375 non-gastric cancer match controls each year for two years. These clinical samples for discovery and validation will allow us to definitively validate if salivary exRNA can be used to detect gastrc cancer in a defined clinical setting (Context of Use). There are four Specific Aims in the UH2 phase of the project. Aim 1 is to randomly select saliva from 100 gastric cancer and 100 non-gastric cancer controls to be used in Aim 2 which is to perform comprehensive RNA-sequencing to comprehensively profile salivary exRNA to the nucleotide level. Aim 3 is to perform data and statistical analysis of the profiled salivary mRNA, miRNA, and snoRNA to select the top 20 salivary ex- mRNA, ex-miRNA and ex-snoRNA. Aim 4 is to verify the candidate exRNA biomarkers in the original discovery cohort. Only verified candidate salivary exRNA will be advanced to the UH3 phase. In the UH3 phase, Aim 5 is to enroll and procure saliva from an additional 750 gastric cancer patients and 750 non-gastric cancer controls. Aim 6 will use 500 of the gastric cancer saliva and 500 matched control subjects from Aim 4 to individually validate the verified candidate salivary exRNA biomarkers and configure a panel of validate exRNA biomarkers with highest performance using logistic regression analysis. The panel will be validated in Aim 7 using saliva from an independent cohort of 250 gastric cancer and 250 non-gastric cancer controls. The goals of this UH2/UH3 application are to demonstrate the clinical utility of salivary exRNA by the discovering and definitively validating salivary exRNA biomarkers for the detection of a human disease condition.

Public health relevance
PUBLIC HEALTH RELEVANCE: Extracellular RNA (exRNA) is an emerging paradigm in cellular communication, biomarker development, therapeutic applications and systemic physiology. This UH2/UH3 project is to test the hypothesis that salivary exRNA biomarker can be developed for the detection of a human disease condition, gastric cancer. The discovered salivary exRNA biomarkers will be determined if they can be definitively validated. The definitive validation of the salivary exRNA for gastric cancer detection will credential the clinical utility of salivary exRNA for biomarker development for human disease detection. __SpecificAimsTextDelimiter__ 2. SPECIFIC AIMS The UH2/UH3 application is to test the hypothesis that salivary extracellular RNA (exRNA) biomarkers can be developed and definitively validated for the clinical utility to detect human diseases. Salivary exRNA (mRNA, miRNA, snoRNA) have been discovered and reported in human saliva. This UH2/UH3 application is to develop salivary exRNA biomarkers in gastric cancer patients with the goal that by the end of year 05 of this project, it will be shown definitively whether salivary exRNA can be credentialed for biomarker development and validated for clinical detection of a human disease condition. Our laboratory was the first to demonstrate the existence of exRNA in saliva, followed by a series of basic mechanistic studies to credential the presence and existence of extracellular RNA, complexed and stabilized by macromolecular complexes, characterization by cDNA library analyses and most recently comprehensive RNA sequencing. Translationally we have proof of concept data that salivary extracellular RNA has been pre-validated for clinical detection of oral cancer, Sjögren's syndrome, pancreatic cancer, breast cancer, lung cancer and ovarian cancer. For this UH2/UH3 application, we select gastric cancer (stomach cancer) to be the human disease condition for salivary exRNA biomarker development. The key rationale for this clinical selection is that we have, since two years ago, a productive collaboration with the Samsung Medical Center and have already procured saliva from 500 cases of gastric cancer and 2250 non-gastric cancer saliva in our biorepository. These are carefully annotated clinical samples that are procured based on the prospective-specimen-collection and retrospective-blinded-evaluation (PRoBE) design using our standard operating procedure (SOP). This existing clinical resource allows for the immediate exploration of biomarker discovery (UH2) followed by a definitive validation of discovered biomarker candidates using independent clinical samples that will permit individual marker validation, panel configuration and then validation of the biomarker panel using additional independent clinical samples. The following are the Specific Aims spanning the UH2 and UH3 phases of this application to discover and validate salivary extracellular RNA biomarkers for gastric cancer detection to permit the definitive evaluation in a defined clinical context (Context of Use). UH2 Phase (Years 1-2): Specific Aim 1: Samples selection, sample preparations and quality assessment for exRNA biomarker discovery (6th month). Randomized selection of 100 gastric cancer saliva samples and 100 non-gastric cancer matched controls for biomarker discovery. Specific Aim 2: Salivary exRNA biomarker discovery (mRNA, miRNA and snoRNA) using comprehensive RNA sequencing (12th month). RNA-seq will be performed on 100 randomly selected gastric cancer saliva samples and 100 randomly selected non-gastric cancer matched control subjects from Aim 1. Specific Aim 3: Data analysis to select and rank salivary extracellular RNA biomarkers for gastric cancer detection (18th month). Specific Aim 4: Verification of candidate salivary exRNA biomarker candidates (24th month). The discovered salivary RNA biomarkers will be verified using qPCR in the discovery set of clinical samples (100/100). Only verified candidates will be advanced to UH3 phase for validation. For UH3 Phase (Year 3-5): Specific Aim 5: Accrual of saliva samples from 750 gastric cancer patients and 750 non-gastric cancer matched controls in a PRoBE-designed setting in a defined clinical context (48th month). Specific Aim 6: Validate individual biomarker association (Odds Ratio) with gastric cancer and construct a multimarker prediction model for diagnosis of gastric cancer using saliva from 500 randomly selected gastric cancer and 500 randomly selected non-gastric cancer matched control subjects. Validated individual salivary RNA biomarkers will be configured to the most discriminatory panel by logistic regression analysis (48th month). Specific Aim 7: Validate the configured salivary exRNA biomarker panel (Odds Ratio) for gastric cancer detection in an independent 250 gastric cancer and 250 non-gastric cancer matched control subjects (60th month).